Reversing Drug Resistance in Tumors with Clickable Antibody Pairs

PROJECT SUMMARY/ABSTRACT – The incidence of gastric and breast cancers is increasing rapidly, rating
fourth and fifth leading causes of cancer mortality worldwide. In patients clinically classified as HER2-positive
(ERBB2 amplification and/or 2+/3+ protein overexpression by immunohistochemistry), antibody-drug conjugates
(ADC) prolong progression-free and overall survival. However, these therapies have low activity in HER2-low
cancer cells, and not all HER2-positive tumors benefit, or even those who initially respond inevitably develop
resistance over time. Guided by preclinical data we obtained in HER2 heterogeneous patient-derived xenografts
demonstrating that an increase in HER-ADC endocytosis enhances therapeutic efficacy, we developed
approaches of antibody delivery that result in a 15.5-fold increase of ADC internalization in cancer cells. Our
novel approach uses pertuzumab and trastuzumab-drug antibodies that click at the surface of cancer cells upon
binding distinct HER2 domains to increase the number of HER2-ADC complexes and further enhance the rate
of HER2-ADC endocytosis. Antibody-PET imaging studies that we have generated demonstrate that our
approach increases the uptake of 89Zr-ADC in heterogeneous tumors containing HER2-high and HER2-low
cancer cells. Here, we will optimize clickable pairs of two epitope-distinct antibody-ADC biomolecules to enhance
tumor targeting and drug delivery in resistant models of breast and gastric cancer. In addition to test the potential
of our approach in cancer cell lines and organoids, we will perform randomized imaging and therapeutic studies
in patient-derived breast and gastric xenografts representing three tumor populations: ADC-eligible tumors of
HER2 heterogeneity, ADC-ineligible tumors, and ADC-resistant tumors. We will determine the molecular imaging
(89Zr-Antibody PET), safety, pharmacokinetic profile, and therapeutic efficacy of ADC alone (no-click) versus
ADC plus pertuzumab conjugated with clicking pairs (click). These randomized preclinical studies will allow us
to identify molecular features that confer drug sensitivity or resistance to this promising investigational approach.
Aim 1 will optimize pertuzumab/ADC clicking pairs with improved tumor uptake and drug delivery when compared
with ADC monotherapies and Aim 2 will validate the use of antibody clicking pairs as a new therapeutic approach.
The two aims will provide important new preclinical data on the use of antibody clicking pairs to enhance drug
delivery, which could provide an excellent foundation for many future investigations, including the clinical
translation of using clicking pairs to enhance drug delivery and the potential broader application to other
membrane receptors and heterogeneous tumors. The long-term translational objectives of the studies proposed
are to establish a foundation for a clinical trial using antibody clicking to prevent or delay drug resistance in
patients with heterogeneous breast and gastric cancers.

Public health relevance
PROJECT NARRATIVE – The vast majority of patients with HER2-positive breast and gastric cancers become refractory to anti-HER2 antibody-drug therapies, and HER2-negative or several other non-breast/non-gastric tumors do not respond to classical anti-HER2 therapy. We found that methodologies increasing the internalization rates of the HER2 receptor can be exploited by antibody-drug conjugates to effectively treat heterogeneous HER2 diseases. This proposal seeks to optimize a methodology of antibody-drug internalization to overcome drug resistance in HER2-positive and HER2-negative tumors.